Leadership and Administrative Core

ABSTRACT
The Leadership and Administrative Core (LAC) will provide administrative and intellectual leadership to
implement the theme of the San Diego Alzheimer’s Disease Resource Center for Minority Aging Research (SD
AD-RCMAR) to address Alzheimer’s Disease and Related Dementias (ADRD) inequities through novel
research targeting multilevel factors to inform interventions focused on Hispanic/Latino, limited English
proficient (LEP) and refugee communities. The LAC will also coordinate the proposed training activities, and
communications and activities between the PIs, the Core Leaders and Core Members, the AD-RCMAR
Scientists and their mentors. It will promote and support the integration of Diversity, Equity, Inclusion and
Accessibility (DEIA) in all activities of the Center. The LAC will have four components to assist in
accomplishing the Specific Aims, including a Center Administrative Unit, Executive Committee, Pilot Project
Review Panel and External Advisory Committee. These components have both unique and complementary
functions to ensure the center operates effectively and efficiently. Further, the LAC will connect with the larger
UC San Diego (UCSD) and San Diego State University (SDSU) research communities to leverage the existing
infrastructure and collaborations between the SD AD-RCMAR, these research communities, and other
NIH/NIA-supported programs. The result will be a true multi-disciplinary partnership between UCSD, one of the
nation’s leading research institutions (UCSD) and SDSU, a research-prolific Hispanic Serving Institution.